Research Training - Mental Health Behavior Genetics

Revised Abstract Section
This proposal seeks continued support for a training program designed for predoctoral and postdoctoral fellows aiming to pursue research careers in mental health behavior genetics. The faculty, comprised of distinguished and actively researching scientists from the Institute for Behavioral Genetics (IBG) and collaborating units, are at the forefront of well-funded studies examining genetic influences on psychiatric disorders, brain function and development, and psychological and cognitive differences, all directly relevant to mental health. Program faculty use a range of advanced techniques including biometrical, statistical, and quantitative genetic methods, bioinformatics, genome-wide analyses, next-generation sequencing, epigenetics, model organism research, and stem cell models to drive significant advancements in the field. To address the growing need for specialized training in translational research and “big data” studies, this proposal requests funding to support 5 predoctoral and 1 postdoctoral trainee. Predoctoral trainees earn doctorate degrees from cooperating academic units and certification in behavior genetics. The training program includes comprehensive education in modern behavior genetics and mandatory training in the responsible conduct of research. Central to the program is the emphasis on research as a core component of training. Postdoctoral trainees engage in a structured program that prioritizes individual research. The program also prepares trainees for research careers in mental health through activities such as supervising students or technicians, hosting seminar speakers and organizing conferences, guest lecturing, participating in a weekly journal club, grant writing, and developing individual professional plans.
This training program has been supported by the NIH for over 40 years and boasts a long history of training leaders in the field. While maintaining the successful elements of the previous iterations, this proposal introduces several enhancements to keep the training at the forefront of research. Under new leadership with a multi-PI model, the program includes several new faculty mentors who bring fresh perspectives aligned with the evolving research landscape. New coursework and faculty expertise offer trainees opportunities to learn cutting-edge techniques, including a new Methods Proseminar that provides hands-on training for both wet and dry lab techniques. By fostering a collaborative environment, the program aims to produce a new generation of researchers equipped with the latest methodologies and a deep understanding of the genetic influences on mental health.

Public health relevance
Revised Public Health Relevance Section This proposal requests funding to sustain a training program in mental health behavior genetics, led by distinguished faculty from the Institute for Behavioral Genetics. The program aims to enhance research skills through comprehensive education and hands-on training in advanced techniques, catering to the growing demand for translational research and “big data” studies. By incorporating new faculty and offering cutting-edge coursework, the program seeks to continue its legacy of training leaders in the field while staying at the forefront of research advances in behavioral genetics.